Modeling the Responsiveness of Sensitive Populations to Genotoxic Agents Using DNA Repair Inhibitors

Project Summary
It is well recognized that conventional toxicology assays exhibit a crucial deficiency. Specifically, their use of
limited numbers of cell lines and rodent strains does not provide information about toxic responses that may
occur in sensitive human populations. Although studying very large numbers of cell lines and laboratory rodent
models could theoretically address this issue, it is not a practical answer. There are simply too many legacy
chemicals and new chemical substances being developed for this to represent a routine testing scheme.
Fortunately, in the area of genetic toxicology, a solution exists. Our innovative approach takes into account the
fact that inter-subject differences in sensitivity to genotoxic agents is predominately due to variable DNA repair
capacity. Our project will develop an efficient, high throughput, in vitro genotoxicity assay platform that provides
information about chemicals’ potential to cause DNA damage in prototypical and sensitive human populations.
The high efficiency of our proposed approach is in part explained by our decision to study a single p53-
competent human cell line (TK6) to generate prototypical genotoxic response profiles. Sensitive population
responses will be modelled by co-exposing cells to each test chemical in combination with a panel of small
molecule DNA repair inhibitors. These inhibitors will be chosen to cover each of the major DNA repair
pathways. In addition to our use of DNA repair inhibitors to efficiently mimic sensitive populations, other
innovative aspects of our project include our use of a multiplexed DNA damage assay to cover multiple
biomarkers of genotoxicity and cytotoxicity, and state-of-the-art benchmark dose software to characterize the
family of dose-response relationships that will be generated for each chemical studied. Once reduced to
practice, we will make the assay available as a set of kit-formatted reagents, and also through fee-for-service
testing.

Public health relevance
Project Narrative Conventional toxicology testing relies on small numbers of cell lines and laboratory rodent strains. This paradigm has a serious deficiency—it does not provide information about toxic responses that may occur in sensitive human populations. The goal of our project is to develop a cost-effective, high throughput, in vitro human cell-based assay that provides information about chemicals’ potential to cause a particular type of toxicity (DNA damage) in prototypical and sensitive human populations. Once reduced to practice, we will make the assay available as a set of kit-formatted reagents, and also through fee-for-service chemical testing.